Development and clinical validation of domain-aware anthropomorphic model observers for task-based image quality assessment

In this project we aim to develop deep-learning anthropomorphic model observers (AMO) as
a substitute for human observers (HO) in studies aimed to assess image quality, defined in a task-
based fashion based on clinical diagnostic performance. An accurate AMO would allow fast and
clinically relevant procedure for optimization of imaging system and algorithm designs. The
proposed AMO methods aim to achieve good generalization, i.e., an AMO developed for images
reconstructed by one algorithm (or scanner setup) should predict HO performance accurately for
a different reconstruction algorithm (or different scanner setting). In other words, a desired AMO
should be tolerant to domain shifts. It is further proposed to design AMO which is aware of its own
limitations and type of images (or organs) it can be used on, so that it does not attempt to evaluate
images it is unsuited to judge. To this end, we propose to augment the AMO with the capability of
domain-awareness to recognize image domain shift, and to provide a mechanism that can be
used to economize the use of HO studies by more efficiently adapting the AMO to newly available
datasets
This project will also aim to overcome common concerns about deep learning being a “black-
box” by leveraging methods from visual psychophysics, such as reverse-correlation. The
advantage of this approach is that the identical procedure had been applied to HO, thus allowing
a direct comparison and interpretation of the resulting receptive fields.
To accurately train, test and clinically validate AMO we will develop a rich, image data sets,
annotated by experts and non-experts, mimicking CT imaging of the liver. Therefore, a key
component of the project will be development of extensive annotated datasets ranging from
numerical simulation, acquisition from 3D printed phantoms to clinical patient data. For image
acquisition we will use simulated, virtual CT and clinical (physical) CT scanning followed by
several reconstruction methods.
We choose to use liver CT imaging as the development platform for AMOs in low-contrast
lesion localization and discrimination tasks. The chosen application is significant by itself because,
despite years of research, there is still no systematic framework for optimization of the many
factors in imaging system design for clinical diagnostic tasks.
We believe that the proposed domain-aware AMO approach and AMO interpretability
methodology will have a substantial and lasting effect not only on the methodology of AMO
development and use, but also on general deep-learning applications in medical imaging.

Public health relevance
Design of medical imaging devices and algorithms requires a quantitative way to measure medical image quality, which has customarily been done using basic numerical metrics (which are too simplistic) or experts reader studies in which clinician view and interpret the images (an ideal approach, but impractical for everyday engineering work). In this project we use deep learning to create so-called “anthropomorphic model observers” that mimic the feedback of expert users, during device development, thus yielding a practical and effective solution to improve the clinical diagnostic performance.